Testing a pre-visit mobile health app to promote adolescent healthcare

Modified Project Summary/Abstract Section

While preventive care guidance recommends primary care clinicians deliver reproductive
health (RH) care to male adolescents, males’ RH care receipt is poor. Clinic-based interventions
can be valuable RH promotion tools for adolescents. Yet, they have mainly focused on RH care
for girls or single topics rather than the recommended RH care package for males. Computer based approaches make it easier to consistently provide evidence-based RH education, in
multiple languages, tailored to individual needs. Using such approaches before the clinic visit can
also make it easier for clinicians’ work flow, such as time constraints and discomfort in discussing
RH. Yet, we are not aware of any computer-based strategies for use in the clinical setting to
promote recommended RH care for male adolescents. Neglecting to provide males with
evidence-based RH care fails to meet their own needs, and compromises their partners’ health.
Health-E You/Salud iTu is a pre-visit, individually tailored, interactive, web-based mobile
intervention shown to improve hormonal contraceptive knowledge, self-efficacy, and use six
months later. It also primes and extends clinicians’ ability to deliver individually tailored care to
patients. The proposed study will adapt the current Health-E You for male adolescents to assess
their RH needs; provide interactive, individually tailored, evidence-based RH information; support
and prepare males’ RH decision-making and visit priorities; and support clinicians’ ability to
individually tailor recommended care. We will then evaluate its acceptability, usability,
satisfaction, and efficacy on RH care receipt and method use among male adolescents
presenting for care at primary care settings. In this R01 proposal, we propose to (1) adapt Health-
E You for use with male adolescents using an iterative Youth-Centered Health Design Process
(YCHD) with males and input from an advisory board of male adolescents and clinicians; (2)
ensure perceived acceptability, usability, and satisfaction of the final Health-E You app among
male adolescent patients and clinicians using a YCHD approach; and (3) test its efficacy to
improve sexually active male adolescent patients’ knowledge, self-efficacy, and behaviors related
to RH care after the visit and method use 2 months later. The current proposal would be the first
to examine the acceptability, usability, satisfaction, and efficacy of a pre-visit, computer-based
intervention to engage male adolescent patients in RH care and method use, where currently no
such strategy exists.

Public health relevance
Modified Public Health Relevance Section Male adolescents have substantial reproductive health (RH) needs; yet despite clinical guidelines that recommend primary care providers deliver RH care to all male adolescents, very few males receive any singular RH service. Computer- and clinic-based strategies have potential to address this gap, but to date, no approaches exist that promote the recommended RH care package for males presenting to care. This project will adapt Health-E You/Salud iTu, a pre-visit, individually tailored, web-based mobile app for use with male adolescents; and will examine its perceived acceptability, usability, and satisfaction among male adolescents and clinicians; and its efficacy on improving male adolescents’ knowledge, self-efficacy, and behaviors about RH care after the visit and method use 2 months later.